Mentoring in Patient-Oriented Research focused on Neurological Complications of Sickle Cell Disease

PROJECT SUMMARY
Sickle cell anemia (SCA) is a rare disease in the United States, affecting primarily African-Americans, who are
often poor, and without a strong health advocacy presence. Neurological complications of the disease are
critically important. Our team has shown that silent cerebral infarcts are progressive; approximately 50% of
adults with SCA will have silent cerebral infarcts and 10% will have an overt stroke by age 30. My patient-
oriented research (POR) program focuses on elucidating the mechanisms of brain injury and assessing infarct
risk in children and adults with SCA. Herein, I propose to become an outstanding patient-oriented research
mentor to a diverse group of undergraduate/graduate students, postdoctoral fellows, and junior faculty trainees
from multiple disciplines and continue to extend my research to better understand the pathogenesis and
burden of cerebral infarcts in adult SCA. Based on strong preliminary data from our research team in adults
and children with SCA, my aims include: 1) to determine in a multicenter collaborative group, the incidence of
new silent infarcts and overt strokes in adults (≥18 years of age) with SCA, with and without infarcts at
baseline; 2) to apply advanced brain imaging methods for stroke risk stratification in adults with SCA across
multiple sites. Newer non-invasive MRI methods such as diffusion tensor imaging (DTI) techniques assessing
white matter microstructure and methods that assess cerebral hemodynamics will identify areas of subtle brain
injury and hemodynamic signatures that may predict increased stroke risk. These imaging methods could then
be applied to future clinical trials focused on applying aggressive stroke prevention strategies for adults with
SCA at highest risk of progressive infarcts. I have involved mentees in each of my aims, developed a formal
plan to train junior investigators in patient-oriented research, and created a formal senior mentoring advisory
committee. I plan to learn new neuroimaging skills for myself and use resources available from my research
program and the Vanderbilt Institute for Clinical and Translational Research to support my mentees. I have a
strong record of funded patient-oriented research and training mentees but require the protected time and
further education to become the inspiring mentor I envision. Mentoring the next generation of patient-oriented
researchers is important for sustaining research progress and creating a legacy of investigators in the
neurological complications of SCA, particularly as the patient lifespan increase. The combination of a
multidisciplinary research team for mentees to learn from, an outstanding research and institutional
environment, and a strong mentoring plan are key to the success of this proposal.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE At least 60% of adults with sickle cell anemia (SCA) will have a silent or overt stroke and remain at high risk of new or recurrent strokes; despite this, basic data are lacking from clinical trials focused on prevention and treatment. I have a strong foundation of mentoring junior faculty, post-doctoral fellows and students and conducting patient-oriented research (POR) and propose to integrate funded research, opportunities to increase mentoring skills, and an exceptional pool of junior investigators from multiple disciplines to become an outstanding POR mentor. I will expand my current SCA research and mentoring program to address unanswered questions regarding the incidence of strokes in adults with SCA and whether advanced neuroimaging methods, including detailed analyses of structural connectivity, will identify those at highest risk for first or recurrent strokes.